Functional decoding of signaling dynamics in single immune cells

Our laboratory was formed during the reporting period. The PI, Dr. Sung, has recruited fellows from diverse backgrounds to begin work on the project. We have acquired a sensitive laser scanning microscope system with a built-in long-term tissue incubation capability. Dr. Sung has trained the new fellows to use the microscope system for long-term live cell imaging experiments. Currently the fellows can perform these experiments independently and are generating quantifiable time lapse data. We are screening various fluorescent Rel (NF-kappaB subunits) fusion protein constructs to determine which fusions will be utilized for constructing knock-in mouse strains by CRISPR-Cas genome engineering. One fellow is improving the image analysis algorithm that Dr. Sung has developed to alleviate the bottleneck in analyzing the time lapse data generated by long-term live cell imaging of NF-kappaB.